Administrative Core

ABSTRAC- ADMINISTRATIVE CORE
There is a need for well-coordinated infrastructure, multi-institutional and multidisciplinary
collaborative networks that target specific populations and facilitate high-quality, cost-efficient and
regulatory compliant research and health care strategies. The Hispanic Alliance for Clinical and
Translational Research (the Alliance) will integrate clinical and translational research
infrastructure and resources across a predominantly Hispanic U.S. jurisdiction to bridge the gaps
between basic and clinical translational research, to address severe health conditions that
disproportionately affect the medically underserved, and highly prevalent among Hispanic
populations. The long-term goal of the Administrative Core of the Alliance is to provide a model
for the optimal management and development clinical and translational research infrastructure in
resource-limited settings that provide care to medically underserved populations. The specific
objective of the Administrative Core will be to establish a leadership and management structure
that will ensure that the Alliance KCA’s and milestones are met effectively and efficiently and
when necessary realign the existing institutional and Alliance resources. This will be
accomplished through three specific aims: 1) Provide an integrated organizational structure,
leadership and advisory support system to effectively supervise, manage and monitor progress
of all the Alliance key component activities/cores leading to achievement of the proposed
milestones; 2) Develop and implement policies, procedures, and practices that ensure efficiency,
sustainability, and scientific and fiscal flexibility to accommodate the changing needs and priorities
of the Investigators, leading to new innovative and competitive areas of clinical and translational
research; 3) Provide timely financial, dissemination, communication and evaluation functions that
promote expansion of innovative clinical and translational research and services and long-term
sustainability of the Alliance. The proposed administrative structure will bring together key leaders
from the participating Institutions and external collaborators, further developing a pre-existing
collaborative structure that has been successful in obtaining external funding and developing
early-stage investigators. It will provide an efficient and integrated governance and administrative
structure that will ensure the optimal and cost-effective utilization of resources. This will ultimately
lead to successful advances in Clinical and Translational research in prevalent conditions in our
population.